NARCOTIC ANALGESICS AND THE REGULATION OF CATECHOLAMINE NEURONS

The role of opiate receptors located on catecholaminergic cells was studied using primary cultures of adrenal chromaffin cells. These cells contain opiate receptors in measurable amounts. Stimulation of these receptors with agonists decreases the release of catecholamines elicited by nicotine. This effect is stereospecific and is reverted by naloxone and diprenorphine. One of the most potent opiate peptides is met-enkephalin-Arg6-Phe7. Probably this peptide coexists with enkephalin in the splanchnic nerve. Upon release it may function as a second chemical signal modulating cholinergic synapses by reducing the number of acetylcholine receptors available.